Structural Biology Studies of a Large DNA Repair Complex

Our research program revolves around understanding the relationship between structure, dynamics, and
function. We are particularly interested in understanding this relationship in large macromolecular
assemblies, which have been recalcitrant to detailed structure and dynamics studies in the past. Our
strategy is to couple high-resolution methyl-based nuclear magnetic resonance (NMR) spectroscopy,
which is capable of probing proteins and their complexes up to ~1 MDa in size, with biochemical and
biophysical techniques to better understand function. Our current focus is the universally conserved and
essential DNA double strand break (DSB) repair complex Mre11-Rad50-Nbs1 (MRN). This protein
complex is at the heart of detecting DNA DSBs and initiating the process of their repair. Several disease
mutations have been noted in MRN, which give rise to immunodeficiency, developmental and
neurodegenerative disorders, and a predisposition to certain cancers. Other sporadic mutations in Mre11
and Rad50 have been found in a number of different cancers. Bacterial and archaeal model systems,
which lack Nbs1, have been the focus of the existing body of X-ray crystallography and biochemical
studies that suggest a role for protein motions in choreographing the various functions of the Mre11-
Rad50 (MR) core complex. Yet, many questions still remain about the interplay of protein structures and
motions and how these relate to and control MR activity. Over the next five years, our goal is to determine
solution state models of key MR assemblies complete with substrate DNAs that mimic different types of
DNA DSBs and to characterize the protein dynamics that occur within these complexes. The NMR-based
studies will be complemented with a variety of in vitro biophysical and biochemical techniques to further
probe domain motions and the wide array of MR activities, as well as in vivo studies in yeast to place
these motions and activities into the context of overall DNA DSB repair. We will also extend these studies
to include disease mutations within MR, which will not only allow us to understand how these alterations
corrupt MR function and lead to disease but will also provide additional avenues for probing the structures,
dynamics, and functional relationships within this complex. Our long-term goals seek to move beyond the
core MR complex. Although the MR studies proposed herein will be performed on the simplified construct
of Rad50, which has been used in all previous x-ray crystallographic studies of MR, we aim to perform, for
the first time, similar studies using full-length Rad50. In total, our research program aims to better
understand how macromolecular assemblies use protein motions to regulate their functions, and in the
process of applying our program to MRN, we will determine the effect that large and small scale motions
have in controlling the first steps in MRN-mediated DNA DSB repair.

Public health relevance
Our research program uses powerful biophysical and biochemical techniques to answer questions about protein structure and motions that lead to function. The essential protein complex that we study is important for helping to maintain the integrity of our genomic DNA. By investigating the three-dimensional structures, the underlining motions, and functions of this protein complex along with mutations that cause disease states, our research program will promote a deeper understanding for how these proteins function normally and how altering these functions leads to disease.